The Yale Cancer Center Calabresi Immuno-Oncology Training Program (IOTP)

Summary: Systemic therapy for cancer has evolved dramatically in recent years with the emergence of
immune modulation therapies that induce responses and prolong survival in multiple malignancies. It is widely
believed that these advances are only the vanguard in a rapidly evolving field. Investigators from Yale School
of Medicine have played key roles in both pre-­clinical and clinical advances in immuno-­oncology. Continued
advancement requires better understanding of primary and secondary resistance to immune therapy, the
biology of immune suppression in the tumor microenvironment, rational drug combinations, drug toxicities and
novel trial designs specific for immune therapies. Hence, there is an urgent need to train junior investigators to
conduct patient-­oriented cancer immunology and immunotherapy studies to accelerate the pace of these
advances. The proposed Immuno-­Oncology Training Program (IOTP) will address this critical need by training
both PhD and MD or MD/PhD Scholars in clinically-­relevant immuno-­oncology and translational immunology.
IOTP will be distinct from existing training programs at Yale as the only one to specifically focus on training of
junior faculty in patient-­oriented research in immuno-­oncology and immunotherapy. IOTP will capitalize on the
wealth of expertise at our institution in immunobiology and immunotherapy. IOTP faculty have extensive track
records of mentorship and are actively pursuing research in these areas. IOTP will be supported by the Yale
Cancer Center (YCC) and will synergize with the Yale Center for Clinical Investigation (YCCI), which will
provide some foundational courses. Key distinguishing features will be didactic and practical training
developed specifically for this program. The two-­year curriculum includes courses on basic immunology and
cancer immunology, immunotherapy-­specific clinical trial design, the Cancer Immunology Forum and an
individually tailored, two-­year Translational Immuno-­oncology research project encompassing both laboratory
and clinical research. A panel of mentors including both a basic and clinical faculty member will be appointed
for each Scholar. Junior faculty within five years of appointment at Yale School of Medicine will be eligible to
apply to IOTP, with up to five scholars appointed at any one time. Consistent with campus-­wide efforts to
encourage diversity, a Recruitment & Diversity Subcommittee is charged with maximizing diversity of the
Scholar population. The program will be led by an Executive Committee comprised of the PI (Dr. Harriet
Kluger, YCC Associate Director for Education and Training) and two Co-­Directors with complementary
expertise (Drs. Madhav Dhodpakar, co-­Leader of the Cancer Immunology Research Program, and Alessandro
Santin, Leader of the Gynecologic Oncology Research Team). In summary, the IOTP will draw upon an area of
profound institutional strength and enable the Yale Cancer Center to focus specifically on cross-­disciplinary
training of scholars in Cancer Immunotherapy, a field in great need of well-­trained basic and clinical scientists
to accommodate its explosive growth.

Public health relevance
Project Narrative: Immune therapies have resulted in prolonged survival for patients with various types of cancer, and are changing the landscape for cancer research and cancer care. Many of the major advances were led by scientists and clinical researchers at Yale School of Medicine. We propose to capitalize on this expertise as well as the rich resources available at Yale to train the next generation of Cancer Immunologists and Immunotherapists capable of conducting translational research to advance patient care.